No Way Around But Through: Mechanisms of Persistence and Remission of Habits in Anorexia Nervosa

Anorexia nervosa (AN) is a serious disorder with a mortality rate among the highest of any psychiatric
illness. Central to the morbidity and mortality of AN is a persistent tendency to restrict caloric intake below the
body's needs, with a specific tendency to limit calories derived from fat. This perplexing behavior is highly
resistant to change, even with a full course of inpatient treatment and weight restoration. Furthermore,
restrictive eating patterns are linked to the high rates of relapse after hospital discharge. In order to improve
outcomes and long-term remission rates, it is critical to better understand the pathophysiology of illness. This
proposal specifically aims to elucidate mechanisms that contribute to the perpetuation of illness and,
conversely, to sustained remission. One putative mechanism of persistent maladaptive behavior is habit
formation, through which learned behaviors become relatively insensitive to goals. Habit behavior is associated
with neural activity in dorsal frontostriatal systems. Here, we will assess habitual and goal-directed behavior
across three experiments to provide an in-depth assessment of the behavioral and neural mechanisms that
support persistence of illness, as well as remission from illness. This comprehensive battery includes an
augmented Two-Step decision task to assess the preponderance of habitual vs goal-directed behavior
(modified to improve habit sensitivity), the Avoidance Habit task to assess habit formation in the setting of
aversive outcomes, and a Pavlovian Instrumental Transfer task to assess how strongly context cues
exacerbate habitual behavior. The task battery will also measure general vs food-specific abnormalities.
Our central hypothesis is that habits contribute to the persistence of illness, whereas goal-directed
behavior contributes to remission. To examine brain and behavior characteristics associated with short and
long-term remission, we leverage our longstanding research unit, which has a successful program for full
weight restoration (acute remission), and has a Research Registry that has been in place for more than a
decade. We will administer our task battery with fMRI to acutely weight restored inpatients with AN (n=80),
individuals in longer-term remission from AN (n=40, recruited from the Research Registry), and healthy
comparison women (HC, n=40). We will also invite all eligible patients in the Research Registry (n=397,
currently) to complete our task battery online, in order to assess habitual vs goal-directed behavior across a
large sample, spanning a range of experiences from relapse to long-term remission after acute weight
restoration. In addition, the acutely weight restored AN sample will be followed for 6 months after hospital
discharge, a time of high relapse risk, to examine longitudinally the association between behavioral and neural
characteristics and outcome. Findings from this study will help determine whether the mechanisms that support
persistence of illness also support remission, thereby clarifying targets for relapse prevention treatment.

Public health relevance
Anorexia nervosa (AN) is a devastating illness, characterized by maladaptive eating behaviors, with substantial morbidity and a mortality rate among the highest of any psychiatric illness. We will extend understanding of behavioral and neural mechanisms by examining the role of habitual and goal-directed systems in illness, and the influence of habit systems on illness persistence versus remission. Our study will answer a critical question about the role of habits in long-term course of AN, and thereby open new avenues for treatment research.